Targeting exploitable vulnerabilities in T-cell Lymphoma

This project was initiated at NCI with the start of the lab in July of 2022 near the end of FY2022. Progress on the Goals and Objectives of this project during FY2022 included safe transport of GEMM, PDX, and cell line models to the NCI Bethesda Campus so that this work could be initiated. Much of the progress in this project during FY2022 has also been focused on securing proper regulatory compliance for the many facets of this project. Additional work on onboarding personnel in the standard operating procedures of the laboratory has been a major part of the effort of this project during FY2022.